Identification of Presinilin downstream targets in neuronal survival

Alzheimer's disease (AD) is the most common cause of dementia and neurodegeneration, but no disease-modifying therapy is available. The Presenilin (PSEN) genes harbor ~90% of the mutations linked to familial AD (FAD), highlighting its importance in AD pathogenesis. These FAD PSEN mutations are mostly missense mutations (>260) scattered throughout the coding sequence, consistent with a loss-of-function mechanism. Presenilin (PS) is essential for learning and memory, synaptic function and neuronal survival during aging, and contains the active site of γ-secretase. Presenilin conditional double knockout (PS cDKO) mice lacking PS expression in the adult cerebral cortex recapitulate key features of AD, including profound age-dependent neurodegeneration, gliosis, inflammatory responses and tau hyperphosphorylation. Studies in C. elegans, Drosophila and cultured mammalian cells showed that FAD mutations impair PS function and γ- secretase activity. We recently developed two knockin (KI) mice expressing FAD PSEN1 mutations, L435F and C410Y, and homozygous KI/KI mice show striking resemblance to PS1-/- mice, including perinatal lethality, abolished γ-secretase activity, impaired neurogenesis and decreased Notch signaling, demonstrating that FAD mutations resemble the PS1-null mutation in vivo. The molecular mechanism by which PS maintains neuronal function and survival is unclear. Identification of PS downstream targets and γ-secretase substrates will not only elucidate the molecular mechanism underlying PS function and dysfunction, but may provide novel therapeutic targets as well. In the current application, we will take advantage of the power of fly genetics to identify PS downstream targets and γ-secretase substrates involved in the regulation of neuronal survival and longevity. Specifically, we will generate conditional mutant flies, in which Presenilin ortholog (Psn) or Nicastrin ortholog (Nct) are inducibly knocked down by shRNA in adult neurons, and then use these mutant flies to screen for γ-secretase substrates involved in mediating neuronal survival and lifespan followed by validation in fly and mouse models (Aim 1). We will also perform whole-genome RNAi-based genetic screens in Drosophila primary cultured neurons to identify RNAi lines that can correct PS dysfunction, and then validate the identified genes in fly models for their abilities to restore PS dysfunction (Aim 2). Completion of the proposed studies will elucidate the molecular pathways by which PS protects neuronal survival during aging and may provide novel targets that can be further explored for disease-modifying therapy of AD.

Public health relevance
Alzheimer's disease (AD) is the most common neurodegenerative disorder, and mutations in the Presenilin genes are the most common cause of the inherited forms of the disease. The molecular pathway through which Presenilin protects neuronal survival during aging is unknown. In this application, we propose to take advantage of the power of Drosophila genetics to identify Presenilin targets that mediate neuronal survival. Completion of our proposed study will elucidate the molecular mechanism by which Presenilin protects neuronal survival and may identify novel therapeutic targets for AD.